The Tumor Microenvironment Niche of Type I conventional Dendritic Cells

PROJECT SUMMARY
This study investigates the ‘reactive’ immune system in tumors, namely the cellular and molecular allies that
allow immunotherapies to work. In particular it studies cells called ‘cDC1’. The overall hypothesis of this
proposal is that a molecule called Granulin functions to regulate immunity in tumors, through its
expression in these cells.
This program is unique in applying spatial transcriptomics together with genetic tools and conventional cellular
immunoassay methods to understand the critical phenotype-biology relationship between critical cDC
populations and their partners. The resultant discoveries will be formative for designing new ways to boost anti-
tumor immunity.

Public health relevance
PROJECT NARRATIVE Some patients’ immune system can be triggered with immunotherapies, leading to their cure. Those patients have a collection of ‘reactive’ immune cells in their tumors, and this proposal will figure out how a particular molecule functions within those cells, leading to cures. The project will also result in the training of an outstanding young scientist.